Biostatistics in Genetics and Genomics Training Program

Summary
With the recent advances in high-throughput biotechnologies and associated flooding of Big Data,
there is an urgent demand and shortage of the next-generation PhD-level scientists who have strong
biostatistical and computational skills to handle Big Data while understanding biology, especially
genetics and genomics. However, traditional training in biostatistics, which emphasizes almost
exclusively on statistical theory and methods, no longer meets the need; similarly, to meet Big Data
challenge, traditional training in genetics could be expanded and strengthened with more training in
biostatistics/data science. As a response, this application continues the development and refinement
of an innovative and interdisciplinary pre-doctoral T32 “Biostatistics in Genetics and Genomics”
(BiG2) training program. The primary mission of this training grant is to prepare Biostatistics,
Genetics and other predoctoral trainees for leadership roles in biomedical research through excellent
training and mentorship in both biostatistics and genetics/genomics. To meet the overarching
objective specified by the NIGMS's RFA, our training program requires completion by each trainee of
required and elective coursework in an affiliated PhD program with extra training in Biostatistics
and/or Genetics, mentored learning through interdisciplinary research projects through lab rotations,
development of critical thinking, communication and networking skills, attendance at and participation
in journal clubs, seminars and national meetings, successful completion of a program of
interdisciplinary research through their dissertation, and future career development, all of which give
our trainees broad training in a rapidly expanding field. The most distinctive feature of the proposed
training program is its interdisciplinary nature integrating both a biostatistical (or
methodological/computational) aspect and a genetic/biomedical aspect. A key is to ensure each
trainee learns how to carry out critical, reproducible, cohesive and interdisciplinary research program,
including collaborating with various biomedical researchers. We request support for 4-5-6-6-6 slots in
years 1-5 for predoctoral trainees from Biostatistics, Genetics and other affiliated PhD programs.
Each trainee is to be funded for two years at the early stage of his/her PhD study, after which his/her
support will switch to projects funded by the faculty mentors' research grants. As measurable
outcomes, in a short term, we will examine the success rates of the trainee's timely completion of
their PhD studies and their job placements; in a long term, it will be determined by the success and
impact of their future careers in biomedical research; in between, it will be their publications, awards
and career transitions around the beginning of their careers.

Public health relevance
Project Narrative Biostatistics is indispensable in the design, implementation and analysis of biomedical and public health studies. As a result, training of the next generation scientists with expertise in biostatistics is crucial to the ongoing health of the nation's biomedical research enterprise. In this application, we request stipend, tuition, and limited travel support for the interdisciplinary training of predoctoral students in biostatistics and genetics/genomics for five years.